PHASE II STUDY OF TAXOL IN PATIENTS WITH ADVANCED NEUROENDOCRINE CARCINOMA

To evaluate the therapeutic effect of taxol in the two most common neuroendocrine carcinomas, islet cell carcinoma and carcinoid tumor.